DNA Replication and Cytokinesis.

Abstract.
The Origin Recognition Complex (ORC), a heteromeric six-subunit protein
complex, is essential for DNA replication. ORC's functions also extend beyond DNA
replication. The smallest of ORC subunits, Orc6 protein, is important for DNA
replication in all eukaryotes. We have shown that in Drosophila Orc6 has an additional
role in cytokinesis through interaction with the septin complex, a highly conserved
polymerizing protein assembly that is critical for cytokinesis in many species and is
recognized as important component of the cytoskeleton. In preliminary studies we
solved the structure of human Orc6 and identified its structural features that contribute
directly to the functions of the protein in replication and cytokinesis. We characterized
the mutations in different domains of Orc6 leading to Meier-Gorlin syndrome (MGS) in
humans, an autosomal recessive disorder characterized by primordial dwarfism and
developmental abnormalities. We showed that despite different underlying molecular
mechanisms these mutations resulted in similar phenotypes, defects in pre-RC
formation and impaired DNA replication. Thus, the diverse molecular functions of Orc6
can be experimentally dissected to obtain a complete understanding of its discrete
roles in the cell. The overall goal of this proposal is to define the distinct mechanisms
of metazoan Orc6 function in DNA replication and in cytokinesis using Drosophila as a
model system. We established a humanized Orc6-based Drosophila model system
which will be used to analyze the effects of naturally occurring and structure-guided
targeted mutations of human Orc6 in protein functions. Regulatory insights into
replicative and non-replicative functions of ORC in metazoans are limited, despite
decades of research. Our completion of this project will help to fill this gap in our
understanding of diverse ORC's functions in metazoans and provide clues as to how a
specific mutation or mis-regulation would lead to growth and developmental defects.

Public health relevance
Project narrative How Origin Recognition Complex (ORC) accurately executes its roles during normal cell cycle and in disease, remains long-standing question in the field. The smallest and most enigmatic of ORC subunits, Orc6 protein, is important for DNA replication in all eukaryotes and also has a function in cytokinesis. Our goal is to define the distinct mechanisms of metazoan Orc6 functions using Drosophila as a model system.